Administrative Core

WAKE FOREST TRANSLATIONAL ALCOHOL RESEARCH CENTER (WF-TARC)
ADMINISTRATIVE CORE
SUMMARY
Jeff Weiner, Center Director
Sara Jones, Center Co-Director
Brian McCool, Scientific Director
The central goal of the Wake Forest Translational Alcohol Research Center (WF-TARC) is to employ rodent,
nonhuman primate, and human subjects to study behavioral correlates and neural substrates associated with
vulnerability (and resilience) to alcohol use disorder (AUD). The Administrative Core provides the
organizational infrastructure and support needed to ensure that the WF-TARC functions optimally and
accomplishes all its goals and objectives. A strong leadership team will continue to oversee WF-TARC
research progress. They are advised by External and Internal Advisory Program Committees comprised of
outstanding researchers with expertise in translational programmatic alcohol research. The major goals of the
Administrative Core are to promote scientific integration across projects, provide biostatistical support to WF-
TARC investigators, enhance scientific rigor and reproducibility, seek out synergistic opportunities with other
WFSM addiction-related Centers, and promote education and outreach related to the scientific aims of the WF-
TARC. These goals will be accomplished through a detailed organizational structure that includes a Steering
Committee, a Biostatistical Support Service, an Education and Outreach Committee, and a highly experienced
administrative support team. This Core will also provide administrative support for the Pilot Project Core that
supports new and innovative translational alcohol research initiatives to complement and expand the scope of
alcohol research supported by this Center. Collectively, this Core will provide the administrative leadership and
infrastructure to best facilitate the integrated translational WF-TARC research projects and pilots, create new
translational alcohol research opportunities at WFSM, enhance the translational alcohol research training
environment at our institution and support ongoing and new alcohol-related outreach activities throughout the
Piedmont Triad region.